Discipline D Track 2

The Michigan Department of Agriculture and Rural Development Laboratory Division's Information Technology (IT) specialist, and FDA Food Emergency Response Network (FERN) program lead have been working with our Laboratory Information Management System (LIMS) LabLynx, State of Michigan Department of Technology Management and Budget (DTMB) and the FDA on the enhancement of the laboratory's IT systems to submit data electronically by integrating the laboratory's IT system with NFSDX. This Data information upload will replace all other uploads for FDA data, including the FERN Portal and eLEXNET by the fall of 2020.

Public health relevance
The Michigan Department of Agriculture and Rural Development plans on enhancing their current data systems to enable them to electronically submit sample analysis data to FDA. MDARD plans to enhance their laboratory Information Technology (IT) systems to submit data electronically by integrating laboratory IT system with NFSDX.